RESUBMIT_Family-focused Digital Intervention for MOUD Initiation and Retention

A. PROJECT SUMMARY
In 2021, 2.5 million U.S. adults had a past-year diagnosis of opioid use disorder (OUD) and 80,000 died of
overdose. Medication for opioid use disorder (MOUD) combined with behavioral therapy is the standard of care
for OUD, but in 2021 only 22% of patients received MOUD. Nearly 50% received no treatment at all, while two
thirds of those on MOUD discontinued within 6 months. Research shows the need for interventions that
promote both initiation and retention on MOUD. Studies also indicate that reducing stigma, addressing quality
of life, and involving a concerned significant other (CSO) such as a parent or other family member may
improve outcomes. This project responds to HEAL RFA-DA-23-053 to “address the overdose crisis” with a
smartphone intervention that incorporates all of these considerations.
FamilyCHESS is a significantly enhanced iteration of our prior CHESS addiction apps, with versions for the
patient and a CSO. FamilyCHESS will contain features that prompt patients to both start (or restart) and stay
on MOUD, use contingency management to reward app engagement, and offer dynamic content to improve
quality of life. The app will incorporate Invitation to Change (ITC), a combination of Community Reinforcement
and Family Training, Acceptance and Commitment Therapy, and Motivational Interviewing.
A.1. Specific Aims, R61 phase: We will (1) develop and test patient and CSO versions of Family-CHESS; (2)
refine and test the recruitment and implementation plans for a large, long-term, community-based randomized
controlled trial; and (3) demonstrate ability to access Medicaid claims data and other key data sets.
A.2. Specific Aims, R33 phase: We will conduct a 12-month trial that randomly allocates 338 patient–CSO
dyads 1:1 to a control vs. FamilyCHESS intervention arm. Dyads in both arms will complete surveys every 4
months. Timeline Followbacks will be used to measure days on MOUD, overdoses, and use of emergency
departments. (1) We will test the following outcomes: Primary: patient's days on MOUD, quality of life.
Secondary: patient's medically treated opioid-related overdoses, emergency visits, % days self-reported opioid
use in past 2 months, days on study before starting MOUD; dyad's family functioning; CSO’s coping style,
feelings of support, and quality of life. We hypothesize that all outcomes will be more favorable in the
intervention arm. (2) We will test whether patient attitudes about MOUD and feelings of support at 8 months
will mediate 12-month outcomes. (3) We will explore whether patient gender, baseline OUD severity, non-
MOUD treatment, and MOUD type moderate effects of arm on primary outcomes. (4) We will examine
implementation-related variables of patients' and CSO’s use and ratings of FamilyCHESS.
This project may be the first long-term, large RCT of a MOUD-focused dyadic intervention. It is designed to
reach the large population of individuals who have either not received or have discontinued MOUD treatment.

Public health relevance
PROJECT NARRATIVE In 2021, 2.5 million U.S. adults were diagnosed with opioid use disorder and 80,000 died of overdose, yet only 22% receive standard care of treatment including medication for opioid use disorder (MOUD) and behavioral therapy, which together is shown to save lives. To address the opioid crisis, this project will (1) develop a smartphone app designed to both prompt individuals to initiate MOUD and stay on it by involving a concerned significant other (e.g., parent, spouse), using contingency management to reward engagement with the app, and offering a menu of services and dynamic content regarding MOUD, communication, change process, stigma, behavioral health, and more, (2) test the effectiveness of the app on opioid use and quality of life outcomes in a large, 12-month trial comparing patient–partner dyads using the intervention vs patient–partner dyads in a control group, and (3) reach out to affected individuals regardless of treatment status or locality via public media. The proposed study has the potential to impact millions of Americans with opioid use disorder, whether in treatment or not, at a time when effective, accessible interventions are needed more than ever to address this devastating crisis.